Novel lipid and glutamine metabolism-based combination therapies for glioblastoma

ABSTRACT
Glioblastoma (GBM) is a highly aggressive brain tumor with a dismal prognosis, necessitating the urgent
development of novel therapies. Recent studies indicate that GBM requires elevated lipid levels for rapid growth.
Our research has revealed that GBM enhances the uptake of low-density lipoprotein (LDL) by upregulating the
LDL receptor, utilizing lysosomal breakdown to access cholesterol and fatty acids (FAs) for growth. Additionally,
GBM contains abundant lipid droplets (LDs), which are also hydrolyzed in lysosomes to release stored
cholesterol and FAs, further promoting GBM growth. Given the reliance of GBM on lysosomal breakdown of
LDL and LDs for essential lipid supply, inhibiting lysosome function to block cholesterol/FAs supply
might be an effective approach to target GBM. Through drug screening, we identified pimozide, a brain-
penetrant antipsychotic medication, as a potent agent that inhibits lysosomal function, effectively suppressing
LDL and LD hydrolysis in GBM cells. Surprisingly, inhibition of lysosome function unexpectedly increased the
expression of the glutamine transporter ASCT2, enhancing glutamine uptake/consumption. This was
accompanied by upregulation of enzymes involved in cholesterol and FA synthesis. Promisingly, our initial in
vivo tests showed that inhibiting glutamine uptake/consumption or lipogenesis, in combination with pimozide,
effectively inhibited tumor growth in orthotopic GBM models without observed toxicities in mice. These
findings support our hypothesis that, in response to reduced lipid supply from lysosomes, GBM enhances
glutamine uptake and consumption to promote de novo lipid synthesis, ensuring survival. We further
hypothesize that inhibition of the glutamine uptake/consumption-lipogenesis axis combined with lysosome
inhibition is an effective approach to target GBM. Our proposed studies aim to elucidate the molecular
mechanisms upregulating glutamine uptake/consumption and lipogenesis in GBM cells upon lysosome inhibition
(Aim 1), and to validate the therapeutic efficacy of targeting these pathways in combination with lysosome
suppression by pimozide in GBM in vitro and in vivo (Aim 2). Successful completion of this study will provide
valuable insights into the intrinsic connection between lysosome function, glutamine metabolism, and lipid
synthesis in GBM, potentially paving the way for new therapeutic approaches to target this deadly cancer.

Public health relevance
Relevance to Public Health Glioblastoma (GBM) is the most common and fatal primary brain tumor in adults, with the median survival rate of merely 12-16 months despite extensive treatments. This application aims to develop effective combination approaches to target GBM by combining inhibition of glutamine consumption-lipogenesis axis with lysosome suppression, and to use this insight to identify safe therapeutics that can effectively combat GBM and ultimately translate these findings to the clinic for treating patients with GBM.